Diversity Supplement to "Impact of Intensive Treatment of Systolic Blood Pressure on Brain Perfusion, Amyloid and Tau in Older Adults (IPAT-study)"

Abstract
Not applicable

Public health relevance
Project Narrative Not applicable